Synthesis of Bioactive Natural Products and Unnatural Congeners

Project Summary/Abstract
Alkaloid natural products have had an immense impact on the field of therapeutic medicine,
and hold promise for the discovery of new neuropharmacological treatments. One area of
proposed research in the Smith Lab concerns the development of new psychoplastogenic
compounds based on the psychedelic lysergic acid diethylamide (LSD). Although derivatives of
LSD have been explored previously over many decades, derivatives bearing various substitutions
on the indole ring of the ergoline scaffold have never been explored. All of these derivatives are
currently only accessible through total synthesis, and potentially can serve as therapeutic leads
for various neuropsychiatric diseases including Parkinson's disease, PTSD, severe depression,
and addiction. Our concise synthetic approach to the scaffold of LSD hinges on the utilization
and chemical modification of widely available heterocyclic aromatic precursors. This strategy
allows for the exploration of chemical space that would otherwise be inaccessible, however
therapeutically enabling.
Synthetic inspiration drawn from our route to these LSD analogs has led us to investigate the
synthesis of marine macrocyclic diamine alkaloids such as the halicyclamines and the sarains.
None of these targets have been synthesized previously. Our modular, yet redox-economic
platform for assembling these structurally complex compounds hinges on employing heterocyclic
starting materials at higher oxidation levels to efficiently access their congeners with lower redox
levels. Innovation in this research direction is mainly strategic, demanding a navigation of
synthetic assembly that has not been traversed previously. This will also demand tactical
advances in chemistry that will undoubtedly shed light on novel reactivity patterns that will be
broadly important within the realm of heterocyclic chemistry.

Public health relevance
Project Narrative Alkaloid natural products have had an immense impact on the field of therapeutic medicine, and hold promise for the discovery of new neuropharmacological treatments. The development of new synthetic strategies to build these important molecules allows for the construction of new matter capable of improving upon the available treatments for crippling ailments such as addiction, depression, post-traumatic stress disorder and Parkinson's. Laboratory synthetic access to these important alkaloid natural products holds immense promise for the development of efficacious and novel neuropharmacological small molecules.